Impacts of transcription elongation on cardiac gene regulation during homeostasis and regeneration

Project Summary
Heart failure is a major cause of death in the US, contributing significantly to the burden of the healthcare
system every year. Despite the heterogeneity of the causes of heart failure, the heart undergoes gene
expression changes during failure resulting in structural and functional defects. Our long-term goal is to
understand the transcriptional regulatory mechanisms that sustain the structure and function of the heart in
homeostasis and that can induce cardiac protective effects or promote cardiac repair upon injury.
In this application, we will use the transcription regulator Rtf1 as a point of entry to address this critical question
in cardiac biology.
Critical roles for transcription elongation in cellular RNA biogenesis have gained increasing attention in recent
years, but how they contribute to the maintenance of cardiac homeostasis and how modulating transcription
elongation might promote cardiac repair in damaged hearts remain elusive. Using both zebrafish and mouse
genetics, we have previously shown that Rtf1 activity is essential for myocardial development. Rtf1 depletion
destabilizes promoter-proximal pausing of RNA Pol II, blocks activation of the myocardial gene program and
prevents myocardial progenitor cell formation resulting in a heartless embryo. In preliminary data leading to
this proposal, we have found that Rtf1 plays important roles in normal and stressed adult hearts. Ablation of
Rtf1 activity in adult cardiomyocytes leads to rapid heart failure with dysregulated cardiac gene expression
and a loss of contractility. In stressed hearts, we observed elevated Rtf1 expression within cardiomyocytes
after injury, suggesting a role for Rtf1 in the cardiac stress response. Overexpression of Rtf1 also promotes
cardiomyocyte proliferation in a zebrafish ventricular resection model. The dysregulated cardiac gene
expression and reduction of epigenetic marks of active transcription in Rtf1-deficient failing hearts suggest
that Rtf1 functions as a key transcriptional regulator for cardiomyocytes. These findings lead to our central
hypothesis that Rtf1 modulates transcriptional pausing and co-transcriptional histone modification to facilitate
efficient mRNA synthesis in cardiomyocytes and thereby sustains cardiac structure and function in normal
and stressed hearts. We have delineated three Aims to interrogate this hypothesis. Specifically, we will
investigate Rtf1-dependent gene expression in cardiomyocytes and decipher the progressive molecular,
cellular, physiological and metabolomic changes occurring during heart failure (Aim 1). We will use an array
of molecular approaches to uncover the molecular basis by which Rtf1 impacts the transcriptome in
cardiomyocytes (Aim 2). We will also investigate how Rtf1 responds to cardiac damage and the potential of
manipulating Rtf1 activity to promote cardiac repair (Aim 3). Accomplishing these aims will not only provide
significant new insights into the regulatory network of cardiac gene expression but also a possible therapeutic
target to promote cardiac health and post-injury repair.

Public health relevance
Project narrative: Heart failure is a major cause of death in the US contributing significantly to the burden of the healthcare system every year. During failure, the heart undergoes gene expression changes that render structural and functional defects and ultimately result in death. This program utilizes mouse as a model to discern the transcriptional regulatory mechanisms important for sustaining cardiac structure and function in normal and stressed hearts.